UM Clinical Neuroscientist Training Program

There is a marked gap between our ability to treat neurologic diseases and our rapidly increasing
understanding of normal nervous system function, disease pathogenesis, and disease pathophysiology.
Improving treatment of neurologic diseases requires considerably improved integration of burgeoning basic
neuroscience with clinical practice across the translational spectrum from basic discovery through translational
and clinical research. An obstacle to improved integration of disease-oriented neuroscience research activities
and more efficient translation is a deficit of appropriately trained clinician-neuroscientists. American medical
schools graduate significant numbers of physicians with substantial research experience, including MD/PhDs
and individuals with significant experience with and formal training in clinical research. The traditional clinical
training structure, however, impedes the ability of these talented and well trained individuals to efficiently
initiate productive, independent research careers. We propose continuation of a residency-fellowship based
training program integrating residency-fellowship based clinical training with mentored research training to
move talented and experienced trainees in Neurology, Neurosurgery, and Neuropathology to the initial stage of
an independent career. The University of Michigan Clinical Neuroscientist Training Program (UMCNTP)
prepares talented clinician-neuroscientists for independent research careers across the full spectrum of
disease-oriented neuroscience research. The UMCNTP is an integrated residency-fellowship program
preparing talented fledgling clinician-neuroscientists for successful applications for initial independent career
support. The UMCNTP melds productive mentored research experience under the guidance of experienced
senior investigators with focused didactic and hands-on career training to prepare UMCNTP trainees for
successful career development applications such as K08, K23, VA CDA, or equivalents. Our residency
programs matriculate talented individuals without significant prior research experience. For those individuals,
the UMCNTP offers an integrated residency-fellowship-PhD training program in Neuroscience and related
disciplines. The UMCNTP features a strong roster of mentors in the Depts. of Neurology, Neurosurgery, and
Pathology, a training program based on highly successful prior experiences with training clinician-
neuroscientists, utilizes excellent career development resources available at the University of Michigan, and
draws on the great diversity and general excellence of the Neuroscience research community of the University
of Michigan.

Public health relevance
Physician-neuroscientists bring indispensable skills to disease-oriented research and facilitate the integration of research and clinical practice. This program will improve the supply of physician-neuroscientists starting independent research careers.